Reversal of copper accumulation for the early prevention of Wilson’s disease

PROJECT SUMMARY/ABSTRACT
Wilson’s disease (WD) is an inherited copper (Cu) overload disorder caused by mutations in the ATP7B gene,
which result in decreased biliary excretion of Cu. As a result, WD is characterized by copper accumulation and
liver cell damage. WD presents with various clinical symptoms, including fatigue, anorexia, jaundice, acute liver
injury and liver cirrhosis, as early as in toddlers with an average age of 9-10 years old at diagnosis. However,
there is no effective treatment available to date. The current treatment is based on the reduction in hepatic Cu
stores either by facilitating the excretion of excess Cu using chelating agents (e.g., D-penicillamine and trientine)
or by inhibiting the intestinal Cu absorption using zinc salts. While there has been a consensus that Cu chelation
is more effective than dietary Cu restriction in managing WD, current Cu chelators have a number of toxicities,
including gastrointestinal disturbance, myelosuppression, infection, thrombocytopenia, induction of autoimmune
diseases, and liver/kidney dysfunction. Considering life-long treatment of WD, there is an unmet need for a new
therapeutic approach to safely remove excess Cu from the liver. This is particularly important for children
because the treatment should be initiated upon diagnosis in pre-symptomatic children identified by family
screening as early as 2 to 3 years of age, in order to prevent progression to severe liver disease. N,N’-bis(2-
mercaptoethyl)isophthalamide (emeramide) is a lipophilic di-thiol metal chelator that has orphan drug designation
for the treatment of mercury toxicity. While emeramide has shown no indication of drug-related adverse events
in animals and in Phase 1 and 2a clinical trials, the drug also binds to several toxic metals (lead and cadmium)
as well as nutrient metals (iron and copper) only when in excess. In preliminary experiments, we found that
emeramide attenuated Cu-induced oxidative stress and reversed cytotoxicity caused by Cu exposure in several
different cell culture models, including hepatocytes. These data suggest that emeramide could remove excessive
Cu from the liver and improve liver damage associated with Cu overload occurring in patients with WD. Thus,
our goal in the proposed research is to determine the in vivo efficacy and toxicity of emeramide in toxic milk mice
that recapitulate WD symptoms in humans and to compare the results with existing Cu chelators. The specific
aims are to determine: 1) if emeramide mitigates Cu deposition in the liver of a mouse model of WD and 2) if
emeramide provides hepatoprotective effects against Cu overload along with improved safety profiles compared
with existing Cu chelators. Our investigation will provide a new therapeutic strategy, likely disease prevention, to
avoid progressive liver disease associated with hepatic Cu accumulation in WD patients, especially in pre-
symptomatic children.

Public health relevance
PROJECT NARRATIVE Wilson’s disease is an inherited disorder that is characterized by increased copper accumulation in multiple vital organs, including liver, brain and eyes, and tissue damage. Copper chelators are clinically used to ameliorate copper-associated physiological complications, but they exhibit significant side effects along with insufficient therapeutic efficacy for necessary chronic treatments, especially for children. This project will extensively test a promising new, safe copper chelation approach for treating Wilson’s disease.